Cell-type-specific functions of GPR3 in Alzheimer’s disease

PROJECT SUMMARY
Alzheimer’s disease (AD) is a major unresolved public health issue. Despite decades of research on amyloid-β
(Aβ) and tau, we do not fully understand the complex molecular and cellular biology of these key disease drivers.
The brain reacts to the pathological accumulation of Aβ and tau with an early and profound neuroinflammatory
response, which includes alterations in the profile, function, and activation of microglia, astrocytes, and
oligodendrocytes. Although neuroinflammation is an integral component and putative driver of AD pathogenesis,
the cell type-specific mechanisms that characterize this response and its impact on cognitive decline are
incompletely understood.
Biased G protein-coupled receptor (GPCR) ligands preferentially activate G protein or β-arrestin signaling
pathways and are leading to the development of drugs with superior efficacy and reduced side effects in several
therapeutic areas. Surprisingly, biased GPCR signaling is a largely unexplored area in AD research. In the
previous funding cycle, we developed a G protein-biased GPCR 3 (GPR3) mouse model that lacks GPR3-
mediated β-arrestin signaling. Using this model, we showed that biased GPR3 mice exhibit normal cognitive and
behavioral functions, which are disrupted in Gpr3-deficient mice. We further determined that biased GPR3
signaling reduces Aβ levels and the Aβ plaque burden and enhances the glial response in a preclinical AD mouse
model. These exciting findings indicate that GPR3 is the first GPCR to modulate both Aβ pathology and the
innate immune response in AD. These studies also establish the strong scientific premise that the largely
unknown cell type-specific functions of GPR3 impact the development and progression of AD. Thus, the major
goal of this R01 renewal application is to test the central hypothesis that biased GPR3 signaling in microglia,
astrocytes, and neurons reduces AD-related pathologies and cognitive decline by promoting protective immune
responses and preserving neuronal function. Aim 1 will determine how biased GPR3 signaling alters microglia
activation and function and AD-related pathways in primary human microglia and in vivo in our AD mouse
models. Aim 2 will determine how biased GPR3 signaling affects the cell-autonomous and non-cell-autonomous
functions of astrocytes in primary human astrocytes and in vivo in our AD mouse models. Aim 3 will determine
the role of biased GPR3 signaling in neuronal function and cognition in directly converted induced neurons (iNs)
from control subjects and AD patients and in vivo in our AD mouse models, respectively. Successful completion
of these studies will establish the in vitro and in vivo impact of biased GPR3 signaling on neuronal- and glial-
dependent pathways and provide proof of concept for the development of safer and more selective GPCR-
targeting therapeutics with more directed pharmacological action for AD.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is the only disease of the top ten leading causes of death worldwide that we cannot prevent, cure, or significantly slow disease progression. The goal of this project is to establish biased signaling of the G protein-coupled receptor (GPCR) GPR3 as an alternative and viable therapeutic target for AD that modulates both amyloid-β (Aβ) pathology and the innate immune response in AD. We will test the hypothesis that biased GPR3 signaling in microglia, astrocytes, and neurons reduces AD-related pathologies and cognitive decline by promoting protective immune responses and preserving neuronal function in in vitro human glial and neuronal models and in vivo in AD murine models.